Equipment Supplement: Methods and Strategies for the Concise Synthesis of Complex Alkaloid Natural Products

Summary of the Request.
We are requesting funds for the purchase of an Agilent 1260 Infinity II LC System to support our ongoing
NIH project R01GM144663-03, “New Methods and Strategies for the Concise Synthesis of Complex Indole
Alkaloids.” This advanced HPLC system, capable of solvent flow rates between 1-10 mL/min, is essential
for both our primary analytical needs and semi-preparative applications. A reliable HPLC is critical for
quantifying product ratios from various reactions, including diastereomers and distinct products, as well as
determining enantiomeric ratios using chiral columns. Our current HPLC, an Agilent 1100 system
purchased in 2005, has become increasingly unreliable, experiencing frequent leaks and severe pressure
spikes that disrupt our research. The acquisition of the Agilent 1260 Infinity II LC System will ensure the
accuracy and reliability of our analytical processes, thereby enhancing the quality and efficiency of our
research. We respectfully request this supplement to maintain the high standards of our ongoing work and
achieve the objectives outlined in our funded project.

Public health relevance
PROJECT NARRATIVE This proposal outlines plans for the development of new methods and general strategies for chemical synthesis of complex, bioactive organic compounds. The results from this endeavor will produce new synthesis “tools” that will enable medicinal chemists in academia, government labs, and the pharmaceutical industry to more easily access intricate molecules that are needed for biomedical studies and for the development of pharmaceutical drugs. The challenging projects that will be examined will provide excellent problem-solving skills and training in synthetic organic chemistry for graduate students and postdoctoral associates and prepare them for careers in biomedical fields.